QUANTITIVE CT IN DEMENTIA

Twenty-seven patients with Alzheimer's disease were compared to 16 elderly normals using quantitative MRI and SPECT. Both structural and functional abnormalities occurred early; however, only blood flow predicted cognitive decline.